iAGREE: A Multi- Center, Networked Patient Consent Study

We have gained valuable knowledge and lessons from our past experience with
contacting patients to participate in research studies and propose to address them in
the iAGREE study. These lessons include the following: Patients are unaware that their
“de-­identified” data can be shared for research purposes without consent, and most
patients do not know their data are being shared for research and who may have
accessed their data for what type of research. Even when identifiable data that involve
an approval process are involved, e.g., genomes, the granting of consent waivers is
highly variable among institutions. Patients are satisfied when given the opportunity to
choose when and with whom to share which portions of their data, and their
participation levels in research did not have an adverse effect with this opportunity.

Through iAGREE, we will meet with stakeholders to define their needs, develop data
sharing policies, and gather their assessment of the fit of the developed platform to their
expressed needs. The developed platform will be an electronic consenting platform that
authenticates patients and records their consent, all queries that use their consented
data, and meta-­data on query results that have been shared with data requestors. We
will dis-­intermediate the process of checking which data can be made available to
researchers by binding researcher requests to data that use a common data model and
redact using the patient consents. Our platform will increase transparency in the use of
patients’ data. For example, any institutional representative can check that patients’
consents were followed in a data request, and patients can view which studies used
their data. Furthermore, patients would only need to make choices once for all
institutions where their data are stored, or choices may be institution-­specific. Patients
will also receive a notification before their data are used to respond to a data request,
and they will have the opportunity to change their data sharing preferences based on
the study information or leave permissions as is.

We will deploy this platform at the seven institutions participating in this project. These
collaborating sites consist of both private and state-­owned institutions, so this project
will uncover policies that meet local as well as state regulations.

Public health relevance
Honoring patient preferences for sharing their electronic health records in a way that meets institutional requirements for adoption is a challenge. Through our study, we propose to find a solution for both, which will result in a system that authenticates patients, allows them to make sharing choices, and change sharing choices based on each study’s parameters. In addition, we will incorporate the needs and input of stakeholders (e.g., patients, institutional leaders, IRB experts) during each stage of the project.